How bacterial SMC complexes organize chromosomes (Equipment Supplement)

Project Summary
The primary goal of our funded research (1R01GM141242) is to understand how the chromosome is organized
and segregated during the cell cycle. We focus on the molecular mechanisms of SMC condensin complex, which
is a key player for chromosome dynamics from bacteria to humans. Our projects combine genetic, molecular,
cytological, and biochemical approaches. All of these approaches require that we grow the bacterial cells to the
desired experimental conditions. In this application for Administrative Supplements for Equipment, I am
requesting the New Brunswick Innova 44R system, which will allow us to continue growing cells to perform the
experiments proposed in the parent grant.

Public health relevance
Project Narrative Faithful segregation of chromosomes underlies genome integrity in all organisms. My R01GM141242 project aims to identify the mechanisms by which broadly conserved structural maintenance of chromosomes (SMC) complexes organize and compact replicated chromosomes in the cell. In this supplement proposal, I am requesting funds to purchase New Brunswick Innova 44R Incubator Shaker to generate bacterial cell cultures for the proposed experiments.